Development of new Pt-based ROS storm inducing polymers with tumor specific toxicity

Abstract
Breast cancer is the second leading cause of cancer-related death of women in the United States, and triple
negative breast cancer (TNBC) is the most aggressive subtype. It comes back early, spreads fast, has a poor
prognosis, and there are limited treatment options. Almost 90% of patients with TNBC that have spread to other
parts of the body will pass away within five years, which is a lot worse compared to other subtypes, and the lungs
are the most common site for TNBC to spread. Current standard therapies including platinum (Pt) drugs, taxanes,
and anthracyclines are widely used but often cause severe toxicity and rapid drug resistance. TNBC responses
moderately to current immunotherapies, and the overall treatment effects are heavily affected by a group of
immune cells in tumor tissues, the immune-suppressing myeloid cells. This population contributes to forming
immune environment which promotes tumor growth by inhibiting immune surveillance. Therefore, novel
approaches are urgently needed to help these patients live longer, particularly for TNBC that spreads to distant
organs such as the lungs, since they are more frequent and deadly.
Reactive oxygen species (ROS) are unstable molecules within cells. While high levels of ROS can be harmful to
cancer cells, they also significantly affect the behavior and interaction of cancer cells and myeloid cells in tumors.
This makes them a promising target for TNBC treatment. However, most of current drugs do not produce
sufficient ROS. Mild ROS not only fail to kill tumor cells but can promote tumor growth. Moreover, the
immunosuppression effect remains a critical concern. It is important to design new drugs with high potency of
ROS production. Accordingly, we have developed novel Pt-based therapeutics that produce robust ROS
production, effectively eradicates TNBC cells rapidly, and successfully suppressed tumor growth in animal
models.
The goal of this project is to investigate the activities and biological mechanisms of these new drugs on both
cancer and immune cells, with a special focus on TNBCs that have spread to lung. We will study the mechanisms
how the drugs kill TNBC cells and assess the effectiveness when combined with current first-line TNBC treatment
strategies. Moreover, we will explore their overall impact on the immune environment in lung metastatic TNBC
nodules. These findings will provide a novel framework for development and assessment of drug efficacy against
TNBC and other cancer types.
Specific Aims: Aim 1: Elucidate how the ROS-generating Pt drug affects TNBC cells and immune-inhibiting
myeloid cells. Aim 2: Assessment the performance of ROS-generating Pt drug in treating lung-spreading TNBC,
along with its impacts on immune response.

Public health relevance
Project Narrative In this proposal, we aim to investigate novel drugs designed to treat lung metastatic triple negative breast cancer (TNBC) by inducing robust reactive oxygen species (ROS) in combination with conventional TNBC therapeutics. The underlying mechanisms of cancer cell cytotoxicity and immune regulation will be comprehensively explored. The success of this proposal will enable us to understand a new mechanism of cancer cell death mediated by these drugs and can potentially improve outcomes for patients with metastatic TNBC in lungs.